Training Program in Approaches to Address Social-Structural Factors Related to HIV Intersectionally (TASHI)

Project Summary: The “Training Program to Address Social-Structural Factors Related to HIV
Intersectionally” (TASHI)
, based at the George Washington (GW) University, is a NIMH-supported T32
predoctoral training program (T32MH130247-02) that fosters the next generation of researchers prepared to
tackle social-structural and intersectional factors that drive HIV and related health inequities. TASHI is currently
structured as 2 years of tuition, stipend and travel support per trainee and has engaged its 4 trainees in
academic coursework, an intersectionality seminar, mentored research, and community engagement.
The Recognize Excellence in Diversity, Equity, Inclusion and Accessibility (DEIA) Mentorship initiative
represents a unique opportunity to extend and sustain TASHI’s impact. The goal of the 1-year supplement is to
leverage our team’s NIH-supported T32 TASHI predoctoral training platform to provide additional in-
depth and tailored mentorship and support to strengthen community-driven health equity research
expertise among a group a cohort of diverse trainees from backgrounds under-represented in
scientific research. The 4 current TASHI trainees are in various stages of their academic program trajectories
(range 2-4 yrs/~5-yr programs). Providing a third year of funding to trainees during the supplement will allow
them to deepen the integration of community engaged research principles and processes in their dissertations
and build the necessary skills to become leading independent investigators in the health equity research field.
Obj. 1: Utilizing the District of Columbia Center for AIDS Research’s Guide for Academic-Community
Partnerships: “Advancing Equity and Fostering Change (AEFC)” as a model, trainees will receive mentorship
and support to integrate the values, principles and processes of the AEFC guide into their dissertations.
Obj. 2: Leveraging collaborations with existing NIH DEIA research training pipeline initiatives and DC CFAR
scientists and community partners, TASHI trainees will disseminate their community engaged health equity
research plans through scientific presentations and peer-reviewed publications with community co-authors.
In Obj. 1, trainees will participate in: biweekly 1-1 tailored mentored meetings with TASHI MPIs Bowleg and
Kerrigan; monthly seminar sessions with TASHI faculty to learn about and consider how to integrate the central
value, principles and six step research process outlined in the AEFC guide into their dissertations. This will
occur though readings, presentations, discussion, and feedback from faculty mentors, community partners and
peers. In Obj. 2, trainees will receive mentorship, support and feedback to produce peer-reviewed publications,
along with community co-authors, from their dissertation work from Aim 1 activities, and develop a collective
publication documenting the use of the AEFC guide in dissertations. Additional dissemination will occur as
trainees share their work with NIH DEIA research pipeline cohorts, and the DC CFAR CPC and SBS Core.
The proposed activities will strengthen TASHI’s impact and offer a model for T32 health equity programs.

Public health relevance
Project Narrative The goal of the proposed supplement to our existing NIMH T32 predoctoral training grant (TASHI) is provide in-depth, tailored mentorship and support to a diverse cohort of existing trainees, all of whom are from groups under-represented in scientific research, to strengthen their expertise in community-engaged health equity research. The proposed activities with help strengthen and sustain TASHI’s impact, support a group of emerging health equity scholars, and offer a model for other health equity focused NIH T32 training grants.